Novel Platform to achieve high avidity of heterodimers for targeted cancer imaging

? DESCRIPTION (provided by applicant): Targeted cancer imaging is critical for fundamental improvements in cancer patient care and current imaging quality and diagnosis accuracy rely heavily on the affinity/specificity between the targeted biomarker and targeting ligand (small molecules, peptides and antibodies). A heterodimeric ligand that simultaneously associates two linked ligands with two different targeting biomarkers provides a broadly applicable approach to convert low affinity ligands (Kdaffinity ~ mM - µM) to the one with high avidity/specificity (Kdavidity ~ nM). Such high avidity heterodimers are usually pursued by: 1) synthesizing a number of heterodimers with different linkers; and 2) measuring their in vitro avidities individually. However the type of cancer cells may vary in different labs and then the receptors density and distance varies accordingly, so that avidity measurements and heterodimer library synthesis (if such a library is not available in the lab) need to be conducted individually again. Even more disappointing is the fact that, once the receptor of interest changes, repeating the entire procedure (including new heterodimer library synthesis and avidity measurement) is required. Therefore, a lack of a generic and rapid optimization platform has been considered as one of the major barriers for the widespread and routine utilization of heterodimeric ligand for preclinical and/or clinical studies. In order to overcome this problem, we propose the first, high-throughput platform for the easy preparation of high avidity heterodimers, which can be broadly applied to various dual-biomarker combinations and different tumors. Such widespread applicable technology will significantly accelerate and/or enhance targeted cancer imaging using heterodimers, particularly in the following situations: 1) targeted biomarker(s) which are expressed in low abundance; and 2) situations where no high affinity (and/or specificity) monovalent ligands are available.

Public health relevance
PUBLIC HEALTH RELEVANCE: With the success and the influx of targeted cancer imaging and therapy, the development of high affinity/specificity targeting probe is extremely desirable. Heterodimeric ligand that simultaneously associates two linked ligands with two different biomarkers provides a broadly applicable approach to convert the low affinity ligands to the one with high avidity/specificity. Although there has been a considerable effort in the development of heterodimeric ligands, optimization of linkers for bivalency still remains as one major unresolved issue since it has been widely observed that the linker dramatically affects the avidity of bivalency. Therefore, utilizing two bioorthogonal ligations, we propose the first, high-throughput, in vitro screening platform for easy preparation of high avidity heterodimers, which can be broadly applied to various dual- receptor combinations and different tumors. Such widespread applicable technology can significantly accelerate and/or enhance receptor-targeted cancer imaging using heterodimers, particularly in the following situations: 1) targeted receptor(s) which are expressed in low abundance; and 2) situations where no high affinity (and/or specificity) monovalent ligands are available. In addition, this platform can also be easily adapted to prepare high affinity homodimers. In this proposal, two peptide ligands, targeting uPAR and Plectin- 1 biomarkers respectively, are selected to pursue the corresponding high avidity heterodimer used for PET imaging of pancreatic cancer at early stage.